Biostatistics Module

PROJECT SUMMARY - BIOSTATISTICS
The Wilmer Biostatistics Center (WBC) has been successful in providing study design and
analytic support to the Hopkins vision research community through its flexible structure that
combines the expertise of Wilmer biostatisticians and epidemiologists with consultants at
Department of Biostatistics at Johns Hopkins Bloomberg School of Public Health. The WBC
has facilitated interdisciplinary collaboration across schools and across institutions through
funding that supports outside consultants. It has also promoted productivity by providing
statistical resources to faculty in a timely and cost-efficient manner. As our researchers become
more successful and expand their research portfolios, the WBC is committed to innovating to
provide more expansive sustainable services through innovative enhancements. The WBC web
presence is expanding to provide more visibility and accessibility, and harnessing web-based
assessment tools to refine capture of metrics of success – information that will help the WBC
grow and improve. The WBC is going beyond providing analytic services to train Wilmer
researchers to be savvy consumers of statistical output. The goal of the WBC is to grow and
adapt with Wilmer researchers to provide expert reliable analytic services and consulting as well
as push frontiers of research in Wilmer through education initiatives, collaboration facilitation,
methodological development and capacity building. In the current proposed funding period, the
center will 1) continue to provide expert and specialized biostatistics and epidemiology services
for ophthalmology research; 2) develop improved tracking of outcomes through web-based
technology; and 3) expand training and educational resources for investigators; and 5) build
capacity in new areas of big data.